Research Capacity Core

ABSTRACT
In recent years the BBRC has been at the forefront of an expansion in Hispanic Health Disparities research at
UTEP, this has led to a new vision involving the reorganization of the Research Capacity Core (RCC) to better
serve the needs of BBRC and other Health Disparities researchers at the institution. While maintaining a
foundational Core Research Resources (CRR) unit, two new units are being developed and operationalized, the
Hispanic Health Hub (H3) and the Integrative Analytics (IA) unit. The CRR unit will provide training, expertise
and equipment in four primary areas: proteomics and metabolomics, genetics and genomics, cellular
characterization, and imaging. The H3 unit will offer services for collecting and storing biospecimen and
biobehavioral data, repository management, and community-engaged research methods consulting. The IA
unit will provide advanced data analysis services, along with database development and training opportunities
for faculty and students. Our goal for the next five years is to further enhance our research capabilities in
Health Disparities research and support the proposed basic science, clinical, behavioral and pilot projects, as
well as other research on campus through more comprehensive and integrated services.
The Specific Aims of the RCC are the following:
Specific Aim 1: Provide technical training and services, and expand cutting-edge equipment and technologies
to support research projects; and assist students, staff, investigators and researchers throughout the border
region and nationally in order to advance critical areas of Hispanic Health Disparities research.
Specific Aim 2: Increase the capacity to conduct basic, clinical, and behavioral research by establishing the
BBRC Hispanic Health Hub (H3) as the nexus for the collection, storage, and retrieval of primary data and
biospecimens from human subjects as well as expertise on community-engaged methods.
Specific Aim 3: Support investigators and students in data organization, analysis, interpretation, and
presentation as well as project design by providing comprehensive computational and data analysis services
(e.g., big data methods, predictive modeling, database creation, biostatistics and bioinformatics) through the
Integrative Analytics (IA) unit.